Role of microRNA-98 in Myocardial Ischemia Reperfusion Injury in Late Pregnancy

Project Summary
The prevalence of heart attack, also known as myocardial infarction (MI), in pregnancy has increased over the
past decades due in part to rising maternal age and lifestyle changes. MI during late pregnancy carries a worse
prognosis than in non-pregnant (NP) women for unclear reasons. The late-pregnant (LP) rodent is more prone
to myocardial ischemia-reperfusion injury (IRI) compared to the NP rodent. Furthermore, reactive oxygen species
(ROS) production in the heart is higher in LP mice subjected to IRI. However, the underlying molecular
mechanisms involved in the higher susceptibility of late pregnancy to IRI are not clear. MicroRNAs (miRs) have
emerged as a powerful novel regulator of gene expression. In the heart, several miRs have been involved in IRI,
suggesting that regulation of their function could be used as a novel cardioprotective strategy. MicroRNA
microarray analysis showed that the expression of microRNA-98-5p (miR98) was highly increased in the LP
heart compared to the NP heart at baseline. Strikingly, miR98 was increased further in the LP heart compared
to the NP heart when subjected to IRI. These miR98 expression dynamics may underlie the higher vulnerability
and predisposition of the LP heart to IRI. miR98 is also significantly increased in the plasma of pregnant women
at high risk of cardiovascular disease compared to healthy pregnant patients and healthy non-pregnant patients
in the reproductive age. In vitro data shows that the expression of miR98 is increased in female cardiomyocytes
subjected to hypoxia/reoxygenation, which mimics IRI. Knockdown of miR98 reduces apoptosis, ROS
production, and inflammatory markers in female cardiomyocytes subjected to H/R. To investigate the mechanism
of action of miR98, TargetScan software was used to predict miR98 targets. STAT3 and PGC-1α were strongly
predicted as miR98 targets. STAT3 and PGC-1α are known negative regulators of reactive oxygen species
production and their deletion in cardiomyocytes in vivo has been shown to predispose mice to peripartum
cardiomyopathy. Expression of STAT3 and PGC-1α are lower in the LP rat hearts subjected to I/R injury
compared to the NP rat hearts subjected to I/R injury. Furthermore, knockdown of miR98 in vitro increases
STAT3 and PGC-1α protein expression, whereas miR98 overexpression reduces their expression, suggesting
they could be targets of miR98. The hypotheses of this proposal are, i) induction of miR98 in LP leads to higher
cardiac vulnerability to IRI via targeting STAT3 and PGC-1α, leading to increased cardiomyocyte death, ROS
production, and inflammation, and ii) miR98 has the potential to be served as a therapeutic modality and as a
biomarker for early prediction of cardiovascular disease in pregnancy.

Public health relevance
Project Narrative Heart disease during pregnancy with no previous history of cardiovascular disease is uncommon; however, its prevalence has increased over the past decades as more women delay their pregnancy. Heart disease during pregnancy bears a worse prognosis than in non-pregnant women for unclear reasons. Here, we propose to study what makes the heart in late pregnancy be more vulnerable to heart disease and to find potential therapeutic targets for the treatment of pregnant women who are at higher risk of cardiovascular disease.